Technical Development and Validation of Synthetic Images in Multiphasic CT Examinations of the Kidneys

PROJECT SUMMARY
CT urography is a three-phase CT technique used clinically in the evaluation of blood in the urine, known as
hematuria. Each of the three phases in CT urography—the non-contrast, nephrographic, and urographic
phases—provide unique information that aid in diagnosing the various causes of hematuria. Unfortunately, three-
phase CT urography requires approximately ~2x the examination time and 3x the radiation dose of a standard
single-phase CT. Previously developed methods for improving the CT urography technique have lower
diagnostic accuracy, are more challenging to interpret, and/or have no savings in examination time.
Our group has developed an innovative and novel technique termed SNICT (synthetic nephrographic phase
images in CT). The SNICT technique uses image processing to reconstruct the nephrographic phase images
from the non-contrast and urographic phases. Our preliminary results with a transformer-based deep learning
SNICT technique have shown high fidelity in synthesizing these nephrographic phase images. As a result, the
nephrographic phase acquisition could be eliminated—effectively reducing the CT urography acquisition from a
three-phase to a two-phase study and reducing radiation dose by 33%. In this R01 project, we seek to further
improve and validate the SNICT technique. We will expand upon our SNICT technique by developing a
diffusion-based deep learning model (Aim 1A), which will provide further improvements in image quality.
Furthermore, we will develop a SNICT technique with dual-energy (DE) CT urography studies that can provide
additional benefits, including a 2x reduction in overall examination time and a radiation dose reduction of 66%
(Aim 1B). Moreover, we will perform a rigorous clinical validation of the SNICT technique (Aim 2), in which
the diagnostic accuracy of the reconstructed images will be assessed and the savings in examination time will
be quantified. Our criteria for success will be to show that synthesized nephrographic phase images are (a) of
equivalent image quality compared to ground truth images, (b) are of equivalent diagnostic quality compared to
ground truth images, and (c) provide significantly reduced examination time compared to the standard image
acquisition. These criteria will ensure that the SNICT technique is clinically actionable as a robust and reliable
image reconstruction technique in CT urography examinations that ultimately provides up to a 66% reduction in
radiation dose and 2x reduction in examination time.

Public health relevance
PROJECT NARRATIVE In this R01 project we will further develop and validate an image processing technique for reconstructing images in CT urography examinations. This evaluation will ensure that the technique is a clinically actionable method for improving CT urography studies. The proposed innovative and novel technique will provide up to a 66% reduction in radiation dose and 2x reduction in examination time.